Identification and characterization of chemical probes for interrogation of the NEK family of kinases in cancer

ABSTRACT / PROJECT SUMMARY
Kinases, a class of proteins with more than 500 members in the human proteome, are important regulators of
biological processes in health and disease. Kinases have proven to be excellent drug targets with more than 70
FDA approved medicines that target kinases. Despite this success, most kinases are understudied, and details
of their functions are poorly understood. The NEK family of 11 kinases (NEK1 through NEK11) is a particularly
understudied set of kinases that play roles in key biological processes like the cell cycle, ciliogenesis, and the
DNA damage response (DDR), all with relevance to cancer and human health. These kinases have emerging
links to numerous cancers, diabetes, inflammatory bowel disease, ciliopathies, and ALS. In this project we will
use an efficient kinase systems-based approach to create an enabling suite of chemical probes, assays,
reagents, and molecular tools to identify NEK family members that have key roles in cancer. These high-quality
compounds and reagents we generate, which we will freely share, will allow scientists to build a deep
understanding of the physiological and pathological roles members of the NEK family play. In Aim 1 we will
create potent and selective inhibitors of each NEK using iterative medicinal chemistry and state of the art in cell
target engagement assays. In a complementary effort for this aim we will also create inducible NEK knockdown
cell lines. In Aim 2, using compounds and the NEK knockdown lines, we will evaluate the role and importance of
each NEK in a suite of NEK and oncology-relevant cell health and cell biology signaling assays, measuring
effects on proliferation, migration, the cell-cycle, DNA replication, and ciliogenesis. In Aim 3 we will
experimentally determine the substrates of each NEK, locate the NEKs in broader kinase-dependent signaling
pathways, and develop genetically targetable kinase activity reporters for tracking NEK activity within the
endogenous cellular environment. Output from this project will include potent and selective NEK inhibitors, NEK
family-wide assays, details on the impact of NEK inhibition and knockdown on key cancer processes, molecular
tools, and NEK substrate and pathway information. Successful completion will provide a framework and the
resources needed to validate individual NEKs as high quality, druggable targets for the treatment of cancer.

Public health relevance
PROJECT NARRATIVE The Never in mitosis A-related kinase (NEK) family of protein kinases is an important, yet understudied, kinase family that has recently been implicated in a variety of disorders, including numerous cancers, ciliopathies, chronic inflammatory diseases, and neuronal disorders. The lack of reliable tools to study NEK function has made it difficult to determine the specific role(s) that NEK family members play in the etiology and progression of these diseases. In the proposed project, we will use a generalizable, family-based strategy to develop a suite of tools, including high quality chemical probes, that will be made freely available to the biomedical researcher community and enable researchers to build a firm understanding of how these understudied kinases contribute to health and disease and validate new druggable targets for cancer drug discovery.